Assessing the integration of tobacco cessation treatment into lung cancer screening

Abstract
Lung cancer accounts for 27% of U.S. cancer deaths. The National Lung Screening Trial demonstrated that
lung cancer screening (LCS) with low-dose computed tomography (LDCT) reduces lung cancer mortality.
Guidelines recommend offering annual LCS accompanied by smoking cessation treatment to high-risk, older
individuals. Payers cover LCS for high-risk individuals, and Medicare requires LCS sites to offer smoking
cessation to current smokers. Health care systems adopting LCS have a critical new opportunity to deliver
tobacco cessation treatment to smokers at a teachable moment. However, an optimal treatment strategy for
these long-term, highly dependent smokers undergoing LCS has not yet been determined, and there are
challenges to integrating tobacco treatment services into high-volume radiology practices.
We propose a hybrid
effectiveness-implementation design to examine the development, integration, and implementation of a novel,
personalized, English and Spanish language, evidence-based smoking cessation intervention into LCS sites in
a large, diverse, integrated health care delivery system, comprised of two networks.
To maximize the reach of
tobacco treatment, smokers will be offered personalized assistance and outreach at up to 3 time points (LCS
test order, scan, and results). We will utilize novel health information technology (IT) platforms to promote
patient outreach and access, using technologies like patient portals, informational videos (Vidscrip), and video-
conferencing. Guided by the Health Belief and Self Regulation models with a chronic disease management
perspective, the multi-component LCS-tailored intervention targets the older, long-term, heavy smokers who
will undergo LCS. It provides counseling support and pharmacotherapy (nicotine replacement therapy [NRT]);
is personalized to smokers' risk perceptions, readiness to quit, and LCS results; and systematic screening and
referral to community-based resources to address social barriers to quitting. A centralized tobacco treatment
specialist will deliver the intervention in a series of proactive motivational telephone- or videoconferencing-
based sessions to sustain patient engagement. A randomized trial with a factorial design will test 3 intervention
components that vary by (1) counseling duration, (2) NRT dose, and (3) systematic screening and referral for
social barriers to quitting among 960 current smokers undergoing LCS at 6 screening sites. The primary
outcome is biochemically-validated 7-day point-prevalence tobacco abstinence rates at 6 months. Exploratory
analyses will identify patient- and LCS-level factors that moderate the relationship between intervention group
and smoking outcomes, including socio-demographic characteristics, medical and smoking characteristics, and
LCS-related factors (i.e., LCS result, time point of study entry). Guided by the RE-AIM framework, we will
conduct a
rigorous mixed methods evaluation
of the intervention's reach, adoption, implementation
(including cost-effectiveness
from provider, payer and patient perspectives),
and maintenance.
Our
program could provide health systems nationally with a sustainable model to integrate tobacco treatment into
LCS screening.

Public health relevance
Project Relevance Lung cancer accounts for 27% of cancer deaths in the United States. The National Lung Screening Trial (NLST) demonstrated that lung cancer screening (LCS) with low-dose computed tomography (LDCT) reduces lung cancer mortality for individuals with 30+ pack-years of smoking history. For those who are still smoking, having an LDCT-LCS test provides a teachable moment to promote smoking cessation and to offer smoking cessation treatment. The optimal way to help smokers undergoing LDCT-LCS to quit smoking is uncertain. This proposal will compare the effectiveness and implementation of the optimal tobacco treatment intervention, across a healthcare system, which could be implemented in radiology sites providing LDCT-LCS nationwide.